PhI/II Study of CD8-Reduced T Cells for Treatment of MDS or AML IND17305 (12/30/2016)

CD4+ T cells control the immune response to viral infections and to nascent cancers. They provide specific
directions to immunologic effector cells including macrophages, B cells, natural killers, and CD8+ T cells, and
endow the adaptive immune system with the capacity to remember past encounters and to respond in a rapid,
coordinated, and sustained fashion. The cardinal event in the escape of tumors from immune surveillance is
the functional decapitation of tumor-specific CD4+ T cells, resulting in the paralysis, or “exhaustion”, of anti-
tumor effector cells. In the absence of CD4+ T cell help, tumor-specific CD8+ T cells upregulate expression of
an inhibitory receptor, PD-1, and become unable to secrete cytokines or to kill tumor targets. Monoclonal
antibodies that block PD-1 “release the brakes” on anti-tumor T cells. However, PD-1 blockade attacks a
symptom and not the cause of the escape from immune surveillance: the loss of CD4+ T cell help. There are
no known methods for reversing tolerance in a patient’s tumor specific CD4+ T cells. Fortunately, CD4+ T cells
from healthy donors can provide the same instructions to revive the endogenous anti-tumor immune response.
The effectiveness of this approach was shown in a recent trial in which standard chemotherapy plus 3 doses of
mismatched related donor lymphocyte infusions (DLI) produced a complete remission (CR) in 80% and two-
year disease-free survival of 39% compared to current therapy of 43% CR and 10% two-year disease-free
survival. However, the presence of CD8+ T cells in the DLI can be associated with unacceptable toxicities such
as sustained donor cell engraftment and lethal graft-versus-host disease (GVHD)., and the use of related
donors may foreclose the possibility of subsequent allogeneic stem cell transplantation from a family donor.
The Johns Hopkins University is collaborating with the sponsor of IND 17305 (Cellunova LLC) to develop CD8-
depleted, HLA-mismatched unrelated DLI for patients with myelodysplastic syndrome after failure of
hypomethylating agents (HMA) or patients with secondary acute myeloid leukema. Standard therapy
comprises cytarabine plus daunorubicin or idarubicin and induces CR in approximately 20-50% of patients,
who then become candidates for curative allogeneic stem cell transplantation. The proposed approach
minimizes the risk of GVHD and preserves the option of allogeneic stem cell transplantation from a family
donor. The first clinical trial will use a standard 3+3 design to establish the maximally tolerated dose (MTD) of
donor CD4+ T cells and provide an estimate of the CR rate at the MTD for the cohort of patients with MDS
failing HMA. The major toxicities to be monitored are toxicities of the CD8 depletion device and toxicities of the
donor lymphocytes. We anticipate that non-sustained engraftment of CD4+ T cells will be associated with an
acceptable safety profile at doses of lymphocytes that will be able to be harvested from an unstimulated,
unrelated donor in a single apheresis session. Reversal of T cell exhaustion and tumor specific responses will
provide the rationale for comparing this novel therapy to the current standard of care.

Public health relevance
Project Narrative Cells of the immune system cooperate to fight growing cancers, with CD4+ “helper” T cells providing critical directions to CD8+ “killer” T cells, but the CD4+ T cells often give up the fight, leaving the cancer patient’s CD8+ T cells lost for what to do. Transfusions of CD4+ T cells from a healthy volunteer donor may provide the critical directions to revive the patient’s CD8+ T cells to resume the fight against cancer with minimal toxicity. The safety and effectiveness of CD4+ T cell transfusions will be tested in patients with blood cancers, but the principle of immune cell replacement therapy can be applied broadly to treat any cancer and perhaps serious chronic viral infections.